Multimodal Investigation of the Neuroimmune System in Opioid Use Disorder

Project Summary
This mentored research career development proposal (K99/R00) is designed to provide the candidate
advanced training, expert mentorship, and hands-on research experience to facilitate a pathway to an
independent research career. The candidate completed graduate training in multimodal functional and
spectroscopic neuroimaging and investigated the neurobiological consequences of nicotine and opioid abuse.
On this solid foundation of clinical neuroscience training, the candidate proposes to develop expertise in
positron emission tomography (PET) imaging to investigate the molecular underpinnings of opioid use disorder
(OUD). To achieve this goal, the candidate will complete a comprehensive two-year plan which will provide
rigorous training in three key areas: 1) PET imaging methodology and analysis; 2) clinical research among
opioid dependent individuals; and 3) responsible conduct in research. The mentorship team has expertise in
PET imaging (Drs. Richard Carson and Kelly Cosgrove) and opioid use disorder (Dr. David Fiellin) needed to
facilitate an exemplary training experience. This plan will be completed in a highly-productive and supportive
training environment at the Yale University School of Medicine. This K99/R00 Pathway to Independence
application will enable the candidate to develop into an independent investigator using multimodal
neuroimaging techniques to study substance use disorders, especially OUD.
The societal consequences of the current OUD epidemic are enormous. There is a tremendous need to
investigate novel treatment targets. Recently, there has been increased interest in the neuroimmune system.
Opioids are known to exert acute proinflammatory effects in both the periphery and brain. Opioid-induced
neuroinflammatory responses may play an important role in the development and perpetuation of OUD.
Preclinical and clinical research has linked opioid-induced neuroimmune responses to opioid craving, opioid-
seeking behavior, morphine tolerance, and opioid withdrawal symptoms. In this application, we propose to use
PET imaging to investigate opioid effects on the in vivo neuroimmune system in two separate and non-
contingent studies. [11C]PBR28 PET imaging of 18kDa translocator protein (TSPO) levels is widely-used to
study the in vivo neuroimmune system. In Aim 1, we will use [11C]PBR28 PET imaging to quantify acute opioid-
induced neuroimmune responses among healthy volunteers using a novel human laboratory paradigm. In Aim
2, we combine PET TSPO imaging with proton magnetic resonance spectroscopy quantification of myo-Inositol
levels, a putative glial marker. Together, this multimodal neuroimaging approach will be used to evaluate the in
vivo neuroimmune system of early-treatment OUD patients vs. well-matched controls. These studies will clarify
the neuroimmune consequences of acute opioid administration and chronic opioid abuse. Elucidation of the
role of the neuroimmune system in OUD may motivate novel treatment strategies and improve relapse rates.

Public health relevance
Project Narrative There is a tremendous need to better understand the neurobiology of opioid use disorder and investigate novel treatment targets, such as the neuroimmune system. This project will provide the applicant with intensive and rigorous training in PET imaging that will be applied to the investigate relationships between opioids and in vivo markers of the neuroimmune system. Successful completion of this training plan and the proposed research projects will launch the applicant's independent research studying substance use disorders.